A Brain Penetrating Bi-functional Transferrin Receptor Antibody-TNF-alpha Decoy Receptor Fusion Protein for Alzheimer's Disease

PROJECT SUMMARY / ABSTRACT
Alzheimers disease (AD) clinical trials have primarily been anti-Aβ and anti-tau centric, however this
single-target therapeutic approach has not been successful so far. The idea that AD can be stopped, or
delayed by targeting a single pathological event, needs revision and a multi-level therapeutic approach is
needed for AD. Limited multi-level approaches have been tested for AD but have failed primarily due to
inappropriate time of treatment, side-effects and lack of brain penetration. A promising multi-level therapeutic
approach is to target TNF-α which plays a central role at multiple stages of AD pathology. Existing biologic
TNF-α inhibitors (TNFIs) are thus a potential treatment for AD, however, do not cross the blood-brain barrier
(BBB). No study still date has developed a BBB-penetrating biologic TNFI for AD and this application aims to
fill this gap, and focuses on the development of a BBB-penetrating biologic TNFI for AD. The model biologic
TNFI in the current application is etanercept, which is a type-II TNF-α decoy receptor (TNFR)-Fc fusion protein.
We have fused TNFR to a chimeric antibody against the mouse transferrin receptor (cTfRMAb), wherein the
cTfRMAb domain acts as a molecular Trojan horse to ferry the TNFR into the brain non-invasively via the
transvascular route. We have recently shown that this BBB-penetrating cTfRMAb-TNFR fusion protein results
in better therapeutic indices than etanercept (non-BBB-penetrating TNFI) in AD mice, underscoring the need
for brain delivery of the biologic TNFI. Our central hypothesis is that systemic administration of cTfRMAb-
TNFR, which modulates both peripheral and neural TNF-α, intervenes at multiple levels of AD pathology and is
thus therapeutic in AD. In the proposed studies, we will utilize two different AD mice (APPswe, PSEN1dE9
double and 3xTg triple transgenic mice), ages 4- and 12-months to mimic early- and late-stage AD, and treat
with vehicle, cTfRMAb-TNFR, etanercept or cTfRMAb systemically 3 days/week for 12-weeks. The following
specific aims will be addressed: Aim 1: Optimize dose-response and therapeutic time-window of the BBB-
penetrating biologic TNFI. The effect on neuropathological hallmarks (Aβ and tau), and clinical hallmark
(cognitive deficit) will be studied using three doses (1mg/kg, 3mg/kg and 6 mg/kg). Aim 2: Characterize the
mechanisms involved in the therapeutic effects of the BBB-penetrating biologic TNFI. The effects on
markers of inflammation, BBB function, oxidative stress and synaptic/neuronal loss will be determined. Aim 3:
Evaluate the adverse effects associated with chronic dosing of the BBB-penetrating biologic TNFI. Both
cTfRMAb- and TNF-α inhibition-relevant adverse-effects will be studied. These studies will help optimize the
lowest dose that results in a high efficacy to toxicity ratio, outline the therapeutic time-window for TNF-α
inhibition, identify mechanisms involved in the therapeutic effects of cTfRMAb-TNFR which may enable the
identification of new targets, and will provide the necessary pre-clinical results that will advance the
development of cTfRMAb-TNFR for AD in humans.

Public health relevance
PROJECT NARRATIVE Biologic TNF-α inhibitors (TNFIs) are a potential treatment for Alzheimer’s disease (AD) but do not reach the brain after systemic administration. The current proposal focuses on the development of a brain-penetrating biologic TNFI for AD that can be administered systemically and delivered to the brain non-invasively.